Subversion of Keratinocyte Function by a Tick Salivary Protein

Summary: Tick feeding affects skin inflammation and allows the transmission of microbes that cause human
diseases. Although host immunity functions to impair tick feeding, salivary glands secrete immunosuppressive
molecules that compromise skin defenses. Among the characterized tick salivary gland components is
sialostatin L2, a multifunctional, versatile, and immunomodulatory molecule involved in cathepsin inhibition and
suppression of a non-canonical NLRC4 inflammasome scaffold. In this R21 application, we show a novel
function of sialostatin L2 whereby this molecule binds to the mammalian high mobility group 1 (HMGB1)
protein, an alarmin highly expressed in keratinocytes. Keratinocytes are the most predominant cells in the skin
epidermis and express HMGB1. Notably, HMGB1 serves as a damage-associated molecular pattern (DAMP)
triggering inflammation via cell-surface pattern recognition receptors. Thus, we postulate that a tick bite leads
to the release of HMGB1 from damaged keratinocytes, and the interaction between HMGB1 and sialostatin L2
blocks downstream immune signaling events, preventing skin inflammation, and enabling tick feeding. Our
central hypothesis is that the sialostatin L2-HMGB1 axis in keratinocytes countermeasures skin immunity. Our
preliminary data show that sialostatin L2 mitigates the HMGB1-triggered proinflammatory response, suggesting
a pivotal role of sialostatin L2 in suppressing mammalian inflammation during ectoparasite feeding. How
HMGB1 signal transduction in keratinocytes is affected by sialostatin L2 remains elusive. Accordingly, Aim#1
of this R21 grant proposal will investigate the immunosuppressive function of sialostatin L2 through inhibition of
HMGB1 signaling in keratinocytes. Aim#2 of this proposal will examine tick feeding in the context of HMGB1
released by keratinocytes. Collectively, we will: (1) uncover a previously unidentified mechanism of epidermal
immunosuppression by a tick salivary molecule; and (2) shed light on the immunological role of alarmins during
ectoparasite feeding.

Public health relevance
Project Narrative: Skin immunity plays a pivotal role in mitigating tick feeding. In this R21 application, we will determine how the salivary protein sialostatin L2 affects alarmin immune signaling in keratinocytes during a tick bite. The epidermis, which interfaces with the external environment, has been neglected when studying ectoparasite feeding on a mammalian host. Collectively, this R21 project will advance fundamental knowledge of tick-borne diseases.